Infertility and Long-Term Health Outcomes Among Hispanic Women with Mexican Heritage

PROJECT SUMMARY
Hispanic women are up to 70% more likely to experience infertility (i.e., trying to conceive for ≥12 months without
success), compared to non-Hispanic white women in the US (NHWW). Recent studies indicate that women with
a history of infertility may be at greater risk of cancer, cardiometabolic diseases, and mortality later in life and
that risk may vary among specific infertility diagnoses (e.g., endometriosis, tubal factor infertility, and polycystic
ovary syndrome). Prior research has shown that the severity, incidence, and risk factor profiles for cancer,
cardiometabolic diseases, and mortality differs between Hispanic women and NHWW. However, there has been
a paucity of research on infertility and long-term health outcomes among Hispanic women, despite Hispanics
being the largest minority group in the US with two-thirds having Mexican heritage. Our proposal will utilize the
Mexican Teachers´ Cohort (MTC), a prospective cohort study of 115,306 women from 12 geographically diverse
states in Mexico who were a median age of 44 (range 20-84) when the cohort began in 2006-2008. MTC has
collected data for 18 years. The MTC will harnesses detailed data on reproductive health, including information
on specific infertility diagnoses (e.g., PCOS, ovulatory, tubal, endometriosis, male factor), infertility treatments,
and pregnancy history. The cohort has validated information on disease endpoints including breast cancer,
ovarian cancer (recently funded by NCI), diabetes, and mortality through linked electronic health records and a
national mortality registry through 2019. In the planned proposal, we will leverage our successful methodology
to validate incident breast cancer, diabetes, and mortality cases (2019-2024), and identify and confirm
endometrial cancer, ischemic heart disease and stroke cases (2006-2024). Specifically, our proposal will: Aim
1. Determine the risk of cancer for women with a history of infertility compared to parous women without infertility;
Aim 2. Determine the risk of cardiometabolic diseases for women with a history of infertility compared to parous
women without infertility; Aim 3. Determine the risk of premature mortality for women with a history of infertility
compared to parous women without infertility. The chronic disease risk for Hispanic women with infertility is not
known despite their high infertility disease burden and unique chronic disease profile. This gap in knowledge
precludes them from benefitting from early screening and interventions which may ultimately reduce morbidity
and mortality. This proposal, utilizing a large, well-characterized resource of women with Mexican heritage, is
the first step towards filling a substantial gap in understanding risk of long-term health outcomes among Hispanic
women, the largest minority group in the US.

Public health relevance
PROJECT NARRATIVE Infertility is a common public health problem that is more likely to burden Hispanic women and may increase a woman’s risk of chronic diseases (breast cancer, ovarian cancer, endometrial cancer, cardiometabolic diseases, and mortality). Within the Mexican Teacher´s Cohort, a prospective cohort of over 115,000 Hispanic women of Mexican heritage followed for 18 years, we will combine data on infertility history and specific infertility diagnoses and treatments to evaluate the relationship between infertility and the risk of chronic diseases and mortality.